CTSA UM1 Program at University of Utah

The vision of the Utah Clinical & Translational Science Institute (CTSI) is to strategically and ethically develop and apply generalizable, reproducible clinical and translational science (CTS) innovations to expand the reach and impact of scientific knowledge. The Utah CTSI works with local, regional, and national partners and collaborators to achieve this vision through four specific aims: (1) Serve as a well-recognized hub for clinical and translational science that promotes opportunities for all people to engage with and benefit from scientific research in a measurable, reproducible, and sustainable manner. (2) Design, develop, and test innovative translational science methods, tools, techniques, and best practices to increase efficiency and reproducibility. (3) Support the implementation and dissemination of translational science innovations and the education and development of the translational science and research workforce. (4) Catalyze the advancement of translational research discoveries from bench to bedside to populations to improve the health of individuals and communities, reducing differences in health outcomes and expanding opportunities for all people to achieve their full health potential. Through comprehensive and integrated workforce development programs, we will train the next generation of clinicians, bench scientists, informaticians, and health service scientists in the translational, ethical, and team science aspects of modern biomedical research. We will create a novel model and ecosystem for engaging stakeholders from all communities across the Intermountain West, in order to ensure that many voices are heard throughout the research life cycle; (potential) participants are informed, engaged, and supported so that participation is accessible to all; and findings are translated into care that supports health and well-being for all. Through our resources and services, we will provide stakeholder engagement, study design and analysis, informatics, ethics, and clinical research infrastructure to the Utah CTSI community (including patients, community members, investigators, and providers). Our Translational Innovation Pilot program will launch novel projects to address generalizable translational science questions, overcoming barriers to accelerate translational research. We will leverage modern informatics techniques to integrate clinical data with other data sources into an easily accessible format to facilitate studies seeking to understand differences in health outcomes. Our CTS Research Program will conduct a series of projects that improve access to research across the translational research lifecycle. Our Strategic Management Team brings together experienced leaders from across the institution, partners, and collaborators to unify our efforts, and ensure efficient administration and implementation of the Utah CTSI's aims. Our Hub Liaison Team will ensure that we have active partner participation in national NCATS and CTSA efforts and promote dissemination of CTS innovations across hubs.

Public health relevance
The Utah Clinical & Translational Science Institute (CTSI) and its local, regional, and national partners and collaborators develop, implement, and disseminate new translational science methods, tools, techniques, and best practices to support translational research. The Utah CTSI facilitates collaborations with patient, clinical, and community stakeholders and trains the next generation of the translational workforce. Together, these efforts aim to increase the efficiency and effectiveness of translational research, and ultimately improve the health of our population—reducing variability in health outcomes and expanding opportunities for all people to achieve their full health potential.